STEM Assessment and Reporting Tracker (START)

PROJECT SUMMARY
!
This collaborative proposal with Oregon's network of Science, Technology, Engineering & Math
(STEM) hubs supports programs' STEM evaluation needs through assessment and real-time
reporting of psychosocial factors that influence STEM identity development and persistence across
diverse student backgrounds. Our collaborative strengths will iteratively develop the STEM
Assessment and Reporting Tracker (START), a robust online evaluation tool for engaging students
with immediate, tailored e-feedback aimed at supporting their STEM development while rapidly
informing STEM programs' efforts. We propose a four phase process: Phase 1 will work with
stakeholders (e.g., teachers, principals, administrators, STEM hubs, STEM programs) to identify
common needs for assessment and reporting. Phase 2 will define informatics architecture and
schema to support reporting outputs, data security, governance structures, and linkage with other
data sources. Phase 3 will apply project-based learning with secondary students and STEM partners
to iteratively develop START's student e-feedback, while Phase 4 will identify educator professional
development needs for sustainability. Together, this project will accelerate the speed that schools and
STEM programs receive summary data about their students to formatively inform programmatic
activities and demonstrate program effectiveness. To achieve this goal, our specific aims will:1)
identify assessment needs, reporting requirements, and repository permissions to support STEM
programs in evaluating students' identity development in STEM; 2) integrate project-based learning
with mentoring activities that connect secondary students with inter-professional near-peer scientists
to co-design START's student e-feedback; 3) determine teacher professional development (PD)
needs for enhancing capacity to use the data and respond to START-identified student needs.
Together, this project aims to enhance students' STEM development and persistence by supporting
STEM programs in the measurement, immediate analyses, and rapid reporting of psychosocial
factors that support students' success in STEM. Our project's significance is further enhanced by
enabling comparative effectiveness research across sites to aid in the future identification of STEM
programmatic features most supportive of STEM identity development and STEM persistence.

Public health relevance
PROJECT NARRATIVE This project aims to enhance students' Science, Technology, Engineering, and Math (STEM) identity development and persistence by supporting statewide schools and STEM programs in the measurement, immediate analyses, and real-time reporting of psychosocial factors that influence students' success in STEM. In collaboration with Oregon's network of STEM hubs, this project will iteratively develop the STEM Assessment And Reporting Tracker (START), a robust online evaluation tool for engaging students with immediate, tailored e-feedback aimed at supporting their STEM development while rapidly informing STEM programs' efforts.